CSHL Computational and Comparative Genomics Course

DESCRIPTION (provided by applicant): The Cold Spring Harbor Laboratory proposes to continue a course entitled Computational and Comparative Genomics, to be held in the fall of 2014 - 2016. The Computational and Comparative Genomics course provides experimental biologists with backgrounds in molecular biology, genetics, and biochemistry with the theoretical background and practical experience necessary to use and evaluate computational approaches to genome annotation and analysis, including protein sequence database searching, multiple sequence alignment, identification of promoters and other genetic regulatory elements, and the integration of sequence information into broader models of biological function. The course also provides computer scientists and mathematicians with an introduction to the algorithms, computational methods, and biological problems that are addressed in biological sequence analysis and computational biology. For post-doctoral fellows, and junior and senior investigators who are interested in changing their research direction towards computational biology, the course provides an introduction to computational biology methods and a survey of future directions. Over a seven day period, the students receive a strong grounding in the both the biological and computer science foundations for genome analysis and practical computer laboratory experience on challenging problems. The course is taught by internationally recognized leaders in the field, who provide hands-on demonstrations of the programs and biological databases they have developed. At the end of the course, students can not only use effectively currently available tools in biological sequence analysis, they can also evaluate critically new computational approaches by considering alternative methods and interpretations, and appreciate the strengths and limitations of computational methods for answering broad biological questions.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Computational & Comparative Genomics is a 6 day course designed to meet the continuing need for training in computational biology, statistics, and computer science for molecular biologists and geneticists with backgrounds in experimental biology. In addition, the course presents problems in biological sequence analysis and biological databases to biologists and computer scientists. The course covers research topics and state-of-the-art techniques that, while essential to interpret genome sequence and large-scale functional analysis data from a perspective that balances the theoretical foundations of the approaches and their experimental and analytical limitations.